Micro-Anatomical Mechanisms of Neuronal Circadian Timekeeping, Output, and Entrainment

Abstract
Circadian clocks orchestrate myriad molecular, physiological, and behavioral processes to insure internal
temporal order and optimal daily timing. In animals, the master clock resides deep within the brain where it relies
on complex neural networks to ensure a robust internal sense of time that can readily synchronize with 24-h
environmental cycle. There is growing consensus that the operation of our master circadian clock under modern
light and social environments contributes significantly to a troubling array of health challenges. Understanding
the neural mechanisms underlying circadian timekeeping and the synchronization of the master pacemaker with
environmental cycles (i.e., entrainment) is therefore critical. A significant barrier to our understanding of the
central circadian clock is the complexity of its constituent neural networks, a complexity compounded by the fact
that clock-containing neurons employ multiple neurochemical signals that act via distinct signaling mechanisms.
Critical clock neurons in both mammals and insects express multiple transmitters – including peptide co-
transmitters - some of which function as local signals across defined synapses while others act as diffusible
signals that act over large distances. Peptide co-release, though a common feature of nervous systems, is not
well understood. Likewise, how clock neurons employ both local and paracrine signals to mediate circadian
timekeeping and entrainment remains enigmatic. Here we propose to study key peptidergic clock neurons in
Drosophila as a model to examine how two neuropeptides released from the same neuron can mediate distinct
behavioral and physiological functions to support robust circadian timekeeping and entrainment. Our work will
not only inform our understanding of circadian timekeeping in the mammalian brain but will also be relevant to
the mechanism of peptide co-release generally.

Public health relevance
Narrative The proper alignment of internal circadian clocks with the 24-hour rhythm of the environment is critical for human health. A central goal of chronobiology is to understand the network properties of brain’s master clock and its modulation by environmental cues. Here we use Drosophila melanogaster, an organism that continues to enrich and inform our understanding of circadian timekeeping in the brain, to understand the signals neurons use to create an internal sense of time and how the microanatomical structures of neuronal clocks support robust circadian timekeeping and the proper synchronization with the environment.